2023 Microbial Population Biology Gordon Research Conference and Gordon Research Seminar

PROJECT SUMMARY
The rich diversity of our microbial world influences every aspect of human life. Since 1985 the Microbial
Population Biology Gordon Research Conference (GRC) has been the premier international meeting on the
evolution and ecology of microbial populations, bringing together up to 200 scientists at the forefront of their
disciplines for 5 days of intense interactions. Its long-term objective is to improve our understanding of the
ecological and evolutionary forces responsible for this diversity. It is preceded by a 2-day Gordon Research
Seminar (GRS) that combines research presentations with mentorship for approximately 75 graduate students
and postdoctoral fellows. The cancellation of the 2021 meetings due to the COVID pandemic was particularly
unfortunate given the expertise and leadership of our community in studying and communicating the evolution
and epidemiology of infectious disease.
The goal of the 2023 Microbial Population Biology GRC and GRS is to understand how real microbes interact
and evolve in nature, with a special emphasis on pandemics. Presenters will build upon decades of model-
system research, often featured at previous conferences in this series, seeking to understand how microbial
populations interact at scales from landscapes and oceans to intracellular mutualisms and disease. Three of
the ten sessions will focus entirely on epidemics and pandemics, one in animal hosts, one in human hosts, and
finally a COVID-19 session with a leading epidemiologist and a medical historian. Health-related themes also
run through most of the other sessions (e.g., interactions in polymicrobial infections, vector-borne infections,
emerging zoonoses, the evolution of antimicrobial resistance, prospects of phage therapy).
We expect the 2023 edition of this conference to be timelier than ever before and more relevant to the mission
of NIAID and other Institutes for its focus on microbes relevant to human health, including the origins and
dynamics of pandemic infections. Our aims are the following: 1) To advance research of not just microbial
population biology but also evolutionary epidemiology and microbiome sciences; 2) To catalyze discussions at
the interface of related disciplines that study similar phenomena in different systems; 3) To provide a diverse,
inclusive, collaborative environment for researchers to share and discuss their latest research on the ecological
and evolutionary dynamics of microbial populations in natural communities, including many associated with
humans that cause disease; 4) To promote interactions between established and junior investigators (students,
postdoctoral trainees, and junior faculty); and 5) To support an independent, affiliated Gordon Research Seminar
(GRS) exclusively for postdoctoral scholars and graduate students to present and discuss their research.

Public health relevance
PROJECT NARRATIVE The 2023 Microbial Population Biology Gordon Research Conference and Seminar bring together scientists and trainees in a highly interactive environment to share groundbreaking research on microbial ecological and evolutionary dynamics. These processes are fundamental to understanding infectious disease in human populations as well as the assembly and function of symbiotic microbiomes. This conference not only advances our understanding of basic microbial biology but also highlights how this understanding can be used to improve disease control and maintenance of healthy microbiomes.